American College of Radiology Imaging Network

[unreadable] DESCRIPTION (provided by applicant): See pages 245 to 254 of the submitted application which address the accomplishments. [unreadable] [unreadable] [unreadable]